Fluorescence Activated Cell Sorter

NIH funded researchers at The University of Tennessee Health Science Center (UTHSC) currently
have critical need for a high-speed fluorescence activated cell sorter (FACS) to be managed by the
UTHSC Flow Cytometry and Cell Sorting (FCCS) Shared Resource Laboratory (SRL). This
application is for funds to purchase a Thermofisher Bigfoot Spectral Cell Sorter that is ideally suited to
meet all of the current and expected future needs of NIH funded researchers at UTHSC. The sorter
configuration will include: five lasers and 48 fluorescence detectors, forward and side scatter (FSC
and SSC) detectors, small particle detectors (SPD), six-way sorting into tubes, multiway sorting into
multiwell plates, indexed single-cell sorting, and integrated class II type A2 biocontainment. The new
sorter is intended to replace a 15-year-old BD Biosciences (BD) FACSAria I SORP sorter with
upgraded sampling fluidics to a FACSAria IIu. The aging FACSAria IIu sorter does not have a 561 nm
yellow-green laser, is limited in its current fluorescence detector configuration, does not have SPD
capability, and can no longer meet needs of NIH funded UTHSC FCCS SRL users. BD has informed
us that future support for that sorter cannot be guaranteed beyond 2024. New replacement parts for
many mechanical and electronic components may no longer be available after 2024 and may only be
acquired by scavenging from similarly aged machines removed from service. The aforementioned
FACSAria IIu is the only cell sorter accessible to all UTHSC researchers.
The recent advent of spectral unmixing as an alternative to traditional peak bandwidth compensation
has improved the distinctive identification of fluorochromes with overlapping peak fluorescence in
multicolor experiments. That improved distinction effectively increases the number of available
fluorochromes that may be used in any given experiment. Spectral unmixing has also dramatically
improved the resolution of dim marker fluorescence from autofluorescence. The uses of spectral cell
sorting by the investigators in this application include but are not limited to: 1) deep profiling and
sorting of infiltrating intratumor immune cells; 2) sorting macrophage, neutrophil, and CD8 T cells
from influenza infected and bacterial co-infected lungs; 3) sorting adipose tissue macrophages into
phenotypically distinct subsets; 4) sorting reporter-expressing cerebellar cells; 5) sorting
oligodendrocyte lineages; 6) sorting mitochondria and exosomes that affect muscle stem cell
development; 7) sorting leukocytes from spirochete-infected mice into lymphoid and monocytic
subsets; and 8) sorting chimeric antigen receptor (CAR) T cells.

Public health relevance
Since its inception in the late sixties and seventies, fluorescence activated cell sorting has become a mainstay for almost all research that involves the analysis and selective isolation of live cells. Monoclonal antibodies to the plethora of intra- and extracellular proteins, such as CD antigens and cytokines, respectively, and probes for cytoplasmic organelles, such as endosomes, nuclei, and mitochondria continue to expand this important research resource. The cell sorter to be acquired with this requested funding is the state-of-the-art for that research resource.